CSHL Structural Biology Short Courses in Crystallography & Cryo-Electron Microscopy

ABSTRACT
Cold Spring Harbor Laboratory (CSHL)’s world-renowned postgraduate course and workshop program
has trained investigators and influenced research in fields ranging from proteomics to yeast biology, from ion
channel analysis to high throughput neuroanatomy. This proposal seeks support to continue two advanced
postgraduate ~two-week residential courses on complementary techniques in structural biology, X-ray
crystallography and cryo-electron microscopy, which together represent twin methodological pillars in the
atomic and near-atomic resolution of macromolecular structures and complexes.
X-ray crystallography and related methods have been the cornerstone of structural biology for half a
century, and remain the techniques of choice for atomic resolution understanding of macromolecules and for
structure guided drug discovery. CSHL’s Macromolecular Crystallography course was initiated in 1988 and
combines laboratory and computational instruction to train course participants in the major techniques used to
determine three-dimensional structures. It is designed for scientists with a working knowledge of protein
structure and function, but who are new to macromolecular crystallography or who wish to increase their in-
depth knowledge of macromolecular crystallography. Alumni of the course, including two alumni who went on
to win Nobel prizes, have gone on to make major contributions in their fields.
Cryo-electron microscopy (cryo-EM) is an emerging technique in structural biology where the biological
sample of interest is prepared under cryogenic (deep-freeze) conditions. The utility of cryo-EM stems from the
fact that it allows the observation of specimens that have not been stained or fixed in any way, showing them in
their "native" environment. The resolution of cryo-EM maps is improving steadily, and in recent years near-
atomic resolution of some structures had been obtained, including those of viruses, ribosomes, mitochondrial
protein complexes, ion channels, and enzyme complexes. CSHL’s course on Cryo-Electron Microscopy was
initiated in 2018 and covers the theory, practice, and application of single particle cryo-EM. Participants in the
course will learn to perform all steps involved in solving high resolution cryo-EM structures, including sample
preparation, microscope alignment, data collection, image processing, and model building.
Both courses will teach participants through extensive hands-on experiments along with lectures and
informal discussions on the theory behind the techniques and the latest developments in automating
experimental and computational procedures, from world leaders in methods development, taking advantage of
the outstanding learning environment of the Laboratory’s course program. Applications are open to a wide
range of students including scientists from universities and medical schools, as well as Ph.D. and M.D.
scientists from industry, aiming to allow students to learn techniques that can be immediately incorporated into
their own research, and also enabling translational approaches including rational drug design.
Trainees accepted into the course program will include advanced graduate students, postdoctoral
trainees, senior scientists and principal investigators; across the program, trainees are diverse and balanced
with respect to gender, with 70% coming from US labs, of whom 15-20% are from under-represented
minorities.

Public health relevance
NARRATIVE Structural biology is the field of science that focuses on understanding the structure, function, and interactions of biological macromolecules, such as proteins and nucleic acids, and their complexes. It involves the use of various experimental techniques, including X-ray crystallography, nuclear magnetic resonance (NMR) spectroscopy, cryo-electron microscopy, and computational modeling to determine the 3D structures of these molecules. The information obtained through structural biology studies can help researchers to understand the molecular mechanisms underlying biological processes including pathogenesis in disease, and can be used to develop new drugs and vaccines by targeting specific molecules and their interactions. This application seeks funds to support the continuation of two laboratory-based short intensive courses on Macromolecular Crystallography and Cryo-Electron Microscopy at Cold Spring Harbor Laboratory, New York. Both courses are designed for scientists with a working knowledge of macromolecular structure and function, but who are new to these twin methodological pillars of structural biology. Trainees include advanced graduate students, postdoctoral researchers and young faculty from throughout the United States and abroad.